Web-based App to Alleviate Loneliness and Isolation in Older Adults at Home

ABSTRACT Loneliness contributes to physical and psychological chronic illnesses, functional decline and mortality in older adults. The fast-growing older population coupled with the worsening shortage of caregivers will soon present our nation with severe societal and economic challenges. Older adults often struggle to maintain quality of life and independence in the presence of chronic diseases and isolation. Socialization has been shown to reduce chronic disease, depression, and to improve quality of life in older adults. Motivation and feedback are essential to continued engagement but doing so through the traditional manner of in-person coaching can be prohibitively expensive. Vigorous Mind (VM) has been providing a web-based platform to promote sustained engagement of older adults primarily in groups in senior living facilities. The platform provides dynamic and tailored content for group activities including reminiscence activities, favorite music and video, adaptive computer games and communication. A new mobile app will be developed to enable older adults at home to connect and participate in group activities in senior centers and independent senior living communities. With the help of the Consortium on Technology for Proactive Care, we will enhance the current VM system with a health coach with automated tailored messaging and incentives for continued engagement and adherence. This will optimize the VM system for home-based deployment, thus expanding the reach and impact of VM to potentially delay or even prevent institutionalization among older adults living independently.

Public health relevance
There is a compelling need for a tool that can alleviate loneliness and increase older adults’ socialization to reduce chronic disease, depression and decline and to improve quality of life in this fast-growing population. The proposed integrated web-based platform represents the first step in the development of environments that combine human and machine intelligence in order to facilitate socialization for older adults and to enhance their quality of life.